Prenatal Alcohol and Neuroimmunity

7. Project Summary/Abstract
Studies in both animal models and human cohorts have demonstrated broad impacts of prenatal alcohol
exposure (PAE) on immune function. We showed, for the first time that PAE results in a more severe and
prolonged course of inflammation in response to immune challenge in adulthood, which appears to have its
origins in a proinflammatory bias that is present from birth. Inflammation, increased gut permeability, and
changes in gut microbiota composition have been implicated in the pathogenesis of wide range of diseases/
disorders, including depression and anxiety. Notably, approximately 90% of individuals with Fetal Alcohol
Spectrum Disorders (FASD) experience mental health problems at some point in their lives, with depression and
anxiety being the most common. Yet links between immune/inflammatory function and mental health outcomes
are not well studied in the FASD field, and to date there are no publications examining PAE effects on gut
structure, function, and microbiota composition, nor whether such changes may underlie alterations in immune
function. The present proposal will fill these gaps by exploring the complex interplay among PAE-induced
alterations in gut structure, function, and microbiota composition, immune function, and emotional dysregulation
(operationalized here as adverse mental health outcomes). The potential beneficial impact(s) of intervention
strategies including pharmacological treatments and fecal transplant will be explored, and a translational
experiment will investigate possible associations between PAE-induced emotional dysregulation and altered gut
microbiota composition in a human cohort. Our goal is to explore potential novel biomarkers of PAE and inform
future clinical strategies to improve health and well-being of individuals with FASD. Our Specific Aims are to:
1) Determine the effects of PAE on gut structure, function and microbiota composition and how these may affect
immune function and set the stage for risk for/resilience to emotional dysregulation; 2) Investigate the
effectiveness of pharmacological treatments in ameliorating PAE-induced alterations in gut structure, function,
microbiota composition, immune function, and emotional dysregulation; 3) Evaluate the efficacy of fecal
microbiota transplantation in ameliorating PAE-induced alterations in gut structure, function, microbiota
composition, immune function, and emotional dysregulation; and 4) Translate this work to a human cohort by
investigating associations among PAE-induced alterations in gut permeability, microbiota composition, and
emotional dysregulation in adults with FASD. Our working hypothesis is that PAE: impacts structure and
function of the gut barrier, leading to increased permeability to luminal products; causes a shift in gut microbiota
composition and altered signaling in the gut-brain axis; and together, these changes may be key drivers of the
early proinflammatory bias and lifelong perturbations in immune function that ultimately negatively impact mental
health status. This research will provide unique insight into factors underlying PAE-related risk and resilience.

Public health relevance
8. Project Narrative Prenatal alcohol exposure (PAE) is an early-life insult that programs developing systems and can predispose the organism to a myriad of health-related conditions, including mental health problems (e.g., depression/anxiety) and immune system dysfunction over the life course. The present proposal will investigate whether altered gut structure and function and shifts in microbiota (bacteria) composition, which are known to increase inflammation in both the brain and the body, may underlie the increased susceptibility to mental health problems seen following PAE. Elucidation of the mechanisms underlying risk for and resilience to mental health problems is critical for improving early intervention strategies and long-term health and well-being for individuals with Fetal Alcohol Spectrum Disorders (FASD).